R-loops at the telomere as a toxic source of genomic instability

Abstract
Damage to telomeres resulting from radiation or exposure to toxic chemicals can lead to cancer and
accelerated aging due to unwanted telomere shortening. Damage may also result from normal processes
including generation of formaldehyde or transcription when RNA is left behind embedded in the DNA in the
form of R-loops. Extensive studies of genomic R-loops have shown them to play both positive roles in
regulation of transcription and harmful roles leading to DNA breakage and mutagenesis. Telomeric R-loops (t-
R-loops) may possibly be the single greatest source of DNA damage at telomeres. T-R-loops occur in normal
human cells and are more abundant in ALT cancer cells and cells mutated in certain DNA methylases that
result in high levels of telomeric RNA (TERRA). Elevated levels of t-R-loops have been linked to telomere
damage and shortening. Radiation, toxic agents such as cisplatin, formaldehyde, and exposure to oxidative
damage are also likely to generate higher levels of t-R-loops. We demonstrated that telomeres are arranged in
large loops (t-loops) and recently made a paradigm-shifting discovery linking t-loop formation to telomere
transcription which generates TERRA and produces t-R-loops which we propose are key to t-loop formation.
Thus, telomeric R-loops may be both toxic and necessary for forming protective t-loops. T-R-loops are more
stable than normal R-loops due to G-quartet formation. The extensive studies of genomic and telomeric R-
loops have all relied on a single assay employing the highly specific S9.6 antibody to DNA/RNA hybrids (DRIP
assay). While having driven the field, this IP assay does not discriminate between one or many R-loops on a
DNA fragment or provide information on the clustering of the R-loops, or their size. For t-R-loops, the IP assay
does not reveal whether there are R-loops within the looped portion of the t-loop or their distribution from the
sub-telomeric regions to the telomere terminus. For the field to progress, such critical information must be
obtained. This can now be done using direct electron microscopic (EM) visualization using methods we have
verified in a plasmid-based R-loop study. In our proposed work we carry out a high-resolution study of the
large (120-240 nt) particles formed by single stranded G-rich telomeric DNA and we propose, TERRA RNA.
This is critical for understanding the structure of t-R-loops and will be done cryoEM. To directly determine the
frequency, location, size and clustering of t-R-loops we will apply a novel affinity isolation for telomeric DNA,
combined with a battery of EM tools. This will be done using cultured HeLa and human ALT cancer lines and
extended to cells treated with toxic chemicals including cisplatin and formaldehyde to introduce crosslinks in
the DNA. A novel chemoptogenomic approach for placing ROS generated 8-oxo-G lesions specifically at the
telomere in cells will be applied in a collaboration and the result on the levels of t-R-loops determined.

Public health relevance
Project narrative This summer student research supplement will provide funds to support an undergraduate student from UNC Chapel Hill in the research laboratory of Dr. Jack Griffith in the Lineberger Comprehensive Cancer Center. Mr. Mantri will work on a project directly related to the goals of the parent NIEHS grant which was funded to support studies of the ends of human chromosomes (telomeres) and how they respond to damage from the environment including oxidative damage, and chemicals. Mr. Mantri will work on studies aimed at revealing how a newly discovered set of telomere encoded proteins respond to insult from DNA damage.